CVM Vet-LIRN Veterinary Diagnostic Laboratory Program

Project Summary/Abstract
As a Vet-LIRN Laboratory the Indiana ADDL will continue to participate in Vet-LIRN activities
including monthly calls and laboratory testing and exercises. This includes analysis of samples
submitted through this cooperative agreement in both the bacteriology and toxicology
laboratories in cases of surveillance and outbreak testing. The ADDL will contribute to the surge
capacity in outbreaks as requested and in accordance with State requirements.
The ADDL will provide analytical data for potential regulatory use through use of standardize
methods, equipment platforms, and reporting methods. The ADDL will participate in proficiency
testing and method training provided by the VPO as well as implementation of standardized
quality management systems.
The ADDL will participate in small scale method development, method validation and matrix
extension work as determined by the VPO, and will participate in the AMR project as a source
laboratory.

Public health relevance
Project Narrative As a Vet-LIRN Laboratory the Indiana ADDL will participate in testing exercises and surveillance testing, as well as methods standardization for potential regulatory use. The ADDL will participate in interlaboratory exercises and will serve as a source laboratory for the AMR project.